Community Engagement Core

Community Engagement Core (CEC) Summary
Community engagement is central to the goals of the Columbia University Northern Plains Superfund Research
Program (CUNP-SRP), which seeks to reduce exposure to arsenic (As), uranium (U), and other metals through
systems science, traditional knowledge, and technology innovation. Tribal communities, similar to other rural
communities, are disproportionately exposed to As and U in groundwater from anthropogenic and geogenic
sources. The Community Engagement Core (CEC) of the CUNP-SRP will partner with tribal communities in
North and South Dakota affected by toxic elements in drinking water. The main objectives of the CEC are to
mitigate exposure to metals in drinking water and prevent related health outcomes through bidirectional and
participatory community engagement, advocacy, citizen science, capacity building, and impact evaluation. The
CEC builds upon a strong collaboration between Columbia University, Missouri Breaks Industries Research, Inc.
(MBIRI), and the Strong Heart Study (SHS). MBIRI is a Native American-owned research firm that has partnered
with tribal nations for 25 years and is centrally located in South Dakota. The SHS is a prospective cohort study
of cardiometabolic disease and its risk factors in Native American populations, ongoing since 1989. The
objectives of the CUNP-SRP CEC will engage all Project scientists and local community members to: (1)
integrate the Northern Plains perspective of diverse tribal and rural community members into all CUNP-SRP
activities (through a Community Advisory Committee, tribal research symposia, and communication portfolio);
(2) provide outreach and education to support evidence-based approaches for improving drinking water quality
in the Northern Plains (including enhanced remediation technology developed by Project 5); and (3) prevent
metal-related cardiometabolic outcomes through nutritional interventions (informed by Projects 3 and 4). To
achieve these aims, we will leverage established partnerships with diverse and multi-tiered stakeholders across
tribal communities including tribal and government partners involved in resources and environment, high school
students and teachers, tribal officials and elders, and community members. The CEC focuses on a community
that is engaged and integrated in all Projects, helping collect water samples and identifying safe drinking water
resources (Projects 1, 2, and 3), understanding the health risks (Projects 3 and 4), implementing prevention
strategies (Projects 1, 3, and 4), adapting novel remediation strategies (Project 5), and providing hands-on
opportunities for SRP trainees and local community members. The CEC will also leverage strong partnerships
with other SRP centers that strive to improve public health in Indigenous communities and other rural
environments. With a commitment to safeguarding tribal sovereignty and the right of citizens and communities
to participate as equal partners in the scientific process, the CEC will play a major role in mitigating groundwater
metal exposures and related disease in Northern Plains tribal communities, making drinking water safer and
promoting healthy traditional diets that improve nutritional status and can prevent cardiometabolic disease.

Public health relevance
Community Engagement Core (CEC) Narrative The Community Engagement Core (CEC) of the Columbia University Northern Plains Superfund Research Program (CUNP-SRP) is a collaboration among Columbia University researchers, Missouri Breaks Industries Research, Inc. (a Native American-owned research firm), a Community Advisory Committee, and numerous local stakeholders striving to mitigate drinking water metal exposure and disease in rural tribal communities in the Northern Plains through community outreach and education. The CEC aims to decrease metal exposure and related disease in tribal communities using a bidirectional participatory approach that improves access to high- quality drinking water resources and promotes healthy traditional diets that improve nutritional status and can prevent cardiometabolic diseases. Central to this approach are the core values of equal participation in science and a commitment to safeguarding tribal sovereignty and the rights of citizens and communities, which are transferable to additional Superfund sites, the Superfund Research Program in general, and more broadly to improve public health.